CHILDREN AND YOUTH RESILIENCE PRIZE CHALLENGE

This is an agreement between the Department of Health and Human Services National Institutes of Health (NIH) National Institute of Child Health and Human Development (NICHD) and the Office of Population Affairs (HHS OPA) in its capacity as the host entity for the HHS Child and Youth Resilience Prize Challenge.
The Children and Youth Resilience Prize Challenge is intended to fund innovative community-led solutions to promote resilience in children and adolescents affected by the COVID-19 pandemic and other disasters.